Mapping Neural Recovery: Visualizing Peripheral Nerve Regeneration and Brain Plasticity Post-Peripheral Nerve Injury

SUMMARY
Traumatic peripheral nerve injuries (PNI) lead to functional loss and incomplete recovery of peripheral nerve
function while also impacting the corresponding brain regions that receive, process, and send out signals to and
from the affected nerves. A prolonged duration of denervation due to PNI have adverse implications for both the
nerve's prognosis and the associated brain regions. Over time, the absence of normal nerve signaling can cause
corresponding brain regions to adapt to the loss, making reintegration more challenging after nerve recovery.
This long-term disconnection between the nerve and brain can lead to motor and sensory skill impairments that
require retraining that takes many years and might often be unsuccessful. To date, a significant amount of work
has been focused on improving accuracy and speed of axonal regeneration, but little has been done to better
understand the implications of simultaneous cortical remapping on nerve regeneration. Since the compensatory
and regenerative processes associated with damaged PNs and their effect on brain plasticity are poorly
characterized there is a critical need to develop novel techniques that can monitor both processes with high
spatial resolution. To address this need, we have developed an optical imaging method capable of simultaneous
imaging of the sciatic nerve and cerebral cortex structure and function in individual mice longitudinally using an
implanted cortical and hindlimb windows. In combination with Thy1-GCaMP6 mice these windows enable
visualizing a variety of calcium related processes in live animal both in the cortex and peripheral nerves over the
entire nerve regeneration process. The goal of this project is to characterize the synchrony between PN post-
injury activity and brain plasticity. To achieve this goal in Aim 1 we will test whether the acute injury evokes
immediate response from the sciatic nerve to the corresponding cortical regions. In Aim 2 we will characterize
longitudinal response of cortical activation and connectivity after sciatic injury and their relationship to nerve
regrowth. Using Arc knockout models, we will investigate how cortical plasticity reflects the sciatic nerve recovery
in the injury and repair models. In Aim 3 we will establish the effect of therapeutic electrical and optogenetic
stimulation on axonal regrowth, and cortical activation. In this aim we will test whether electrical stimulation on
the nerve could modulate functional connectivity and whether cortical stimulation could affect nerve recovery.
Overall, this research will bridge the gap in our understanding of how the central and peripheral nervous systems
interact during the recovery from PNI. By developing a deeper understanding and providing new treatment
approaches, we can significantly improve outcomes for individuals suffering from traumatic PNI.

Public health relevance
PROJECT NARRATIVE Peripheral nerve injuries affect over one hundred thousand people in the US each year. The role of cortical plasticity in response to these injuries is not well understood. Our study will employ a novel optical imaging technique to explore the fundamental relationship between peripheral nerve injury, and changes in brain plasticity in live animals, with the ultimate translational goal to improve nerve regeneration.